Patient-centered rehabilitation and dexterous assistive devices for stroke patients using bionic exoskeletons controlled by non-invasive electromyography

No change from original application.

Public health relevance
No change from original application.